Extra-translational roles of aminoacyl tRNA synthetases in connection to disease

DESCRIPTION (provided by applicant): Extra-translational role of aminoacyl-tRNA synthetases in connection to disease Abstract: My goal is to understand the expanded functions of glycyl-tRNA synthetase (GlyRS) and how they connect with Charcot-Marie-Tooth (CMT) diseases. GlyRS is one of 20 members of the aminoacyl-tRNA synthetase (AARS) family that catalyzes aminoacylation of transfer tRNAin the first step of protein synthesis. Dominant mutations of GARS (gene for GlyRS) and YARS (gene for tyrosyl-tRNA synthetase) have been identified in the human population to cause Charcot-Marie-Tooth (CMT) diseases. Also known as hereditary motor and sensory neuropathies, CMT diseases are the most common heritable peripheral neuropathy, occurring with a frequency of approximately 1 in 2500 individuals. The CMT phenotype does not arise from a reduction in the essential aminoacylation function. This observation led to our hypothesis that these two tRNA synthetases have expanded functions (beyond aminoacylation) that are critical to understanding their connection to CMT. The focus of the proposal is on GlyRS. A search for interaction partners of GlyRS identified Daxx, a protein that interacts with the cytoplasmic domain of Fas. Fas is a member of the tumor necrosis factor receptor superfamily, and the Fas-Daxx interaction enhances Fas-mediated apoptosis. Significantly, The Fas-Daxx pathway is implicated in CMT, as well as in many other neurological disorders including Amyotrophic Lateral Sclerosis and Parkinson's disease. These considerations raised the possibility that the interaction between GlyRS and Daxx is relevant to the CMT disease-causing mechanism. Surprisingly, we found that a modified form of GlyRS specifically interacts with Daxx. We have identified the modifier of GlyRS to be a ubiquitin-like protein called NEDD8. NEDDylation is known to regulate the function of its substrates. Interestingly, the residue on NEDD8 for conjugation to substrate is the C-terminal glycine, which is conserved in ubiquitin and in almost all ubiquitin-like proteins. The first reaction in NEDDylation is the adenylation of the C- terminal glycine by condensation with ATP. It is chemically the same reaction as the first step of catalysis by GlyRS in aminoacylation. This consideration led us to propose that GlyRS is involved in the NEDDylation of Daxx which, in turn, regulates Daxx-mediated apoptosis. Indeed, we found that GlyRS-associated Daxx is NEDDylated. Thus, the work proposed here will advance understanding of the extra-translational roles of AARS and their possible connection to human disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Narrative This project will aid in understanding how tRNA synthetases function in connection to Charcot-Marie-Tooth disease, which is the most common hereditary neuropathy. The knowledge we gain in this study will also shed light on other neurological diseases such as Amyotrophic Lateral Sclerosis (Lou Gehrig's disease) and Parkinson's disease. Narrative This project will aid in understanding how tRNA synthetases function in connection to Charcot-Marie-Tooth disease, which is the most common hereditary neuropathy. The knowledge we gain in this study will also shed light on other neurological diseases such as Amyotrophic Lateral Sclerosis (Lou Gehrig's disease) and Parkinson's disease. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS My goal is focused on understanding the expanded functions of glycyl-tRNA synthetase (GlyRS) and how they connect with Charcot-Marie-Tooth (CMT) diseases(1, 2). GlyRS is one of 20 members of the aminoacyl-tRNA synthetase (AARS) family that catalyzes aminoacylation of transfer tRNA in the first step of protein synthesis that is essential for all cells. Specifically, GlyRS ligates glycine to tRNAGly. Surprisingly, dominant mutations of GARS (gene for GlyRS) and YARS (gene for tyrosyl-tRNA synthetase or TyrRS, another member of the AARS family) have been identified in the human population to cause Charcot-Marie-Tooth (CMT) diseases(3-10), the most common heritable peripheral neuropathy. Interestingly, the CMT phenotype does not arise from a reduction in the essential aminoacylation function(9, 11). This observation, combined with recent work showing the involvement of several human AARSs in cell-signaling activities(12-17), led us to propose that these two tRNA synthetases have expanded functions (beyond aminoacylation) that are critical to understanding their connection to CMT. My focus at present is on GlyRS. Our search for interaction partners of GlyRS identified death-domain-associated protein (Daxx), a protein that interacts with the cytoplasmic domain of Fas (a member of the tumor necrosis factor receptor superfamily) and enhances Fas-mediated apoptosis(18, 19). Significantly, we found that a modified form of GlyRS interacts more strongly with Daxx than does unmodified GlyRS. We have identified the modifier of GlyRS to be a ubiquitin-like (Ubl) protein called NEDD8. Importantly, we also found Daxx to be NEDDylated. Thus, the NEDD8-GlyRS species we detected may be an intermediate in the pathway to synthesis of NEDD8-Daxx. NEDDylation is known to regulate the function of its substrates(20, 21). Interestingly, the residue on NEDD8 for conjugation to substrate is the C-terminal glycine, which is conserved in ubiquitin and in almost all Ubl proteins. The first reaction in NEDDylation is the formation of glycyl-AMP (Gly-AMP) through the C-terminal glycine of NEDD8. This reaction is identical to the GlyRS-catalyzed synthesis of Gly-AMP in the first step of aminoacylation(22). This consideration led us to propose that GlyRS acts as an activation enzyme for NEDDylation. Alternatively or additionally, the interaction of GlyRS with Daxx also raises the possibility of GlyRS acting as a conjugation or ligation enzyme for the NEDDylation of Daxx which, in turn, regulates Fas- Daxx-mediated apoptosis. Significantly, the Fas-Daxx mediated apoptosis pathway is implicated in CMT(23, 24), as well as in many other neurological disorders including Amyotrophic Lateral Sclerosis(25) and Parkinson's disease(26). Therefore, the connection between GlyRS and the Fas-Daxx pathway in neuronal cell homeostasis is likely to be relevant to the CMT disease-causing mechanism. The two specific aims of the proposal are: Aim 1. Test the role of GlyRS in Neddylation Hypothesis: GlyRS, with aid of its intrinsic binding pocket for glycine, expands the enzymatic function from aminoacylation to NEDD8 modification of Daxx. Aim 2. Test the role of GlyRS in neuronal cell homeostasis Hypothesis: GlyRS protects neurons by inhibiting Fas-Daxx mediated apoptosis. The protective role of GlyRS is disrupted by the CMT-causing mutations. 1